Enhanced Safety and Health Training for Western Mine Workers

Project Summary/Abstract
The Colorado School of Mines (CSM) Energy, Mining and Construction Industry Safety (EMCIS)
Program is a highly respected and well-established training organization that was initially formed
in 1999 as the CSM Mine Safety and Health Program. With mining at its core, CSM operates its
training center to enhance the quality and availability of health and safety training for Western
mine workers and underserved industry populations. Goals include providing workers with
relevant knowledge regarding hazards associated with working on mine sites and effective
controls for reducing risk for injuries and illnesses. In addition, trainees will be strongly
encouraged to be active participants in improving the health and safety conditions where they
work. CSM proposes to offer a comprehensive approach to meet the safety and health training
needs of the Western mining industry by providing a high quality, interactive training experience
that specifically targets mine workers and other at-risk audiences engaged in mining and
mineral exploration. , In addition to workers directly employed by mining and resource
companies, CSM's training program is designed to effectively serve underrepresented industry
sectors, such as contractors, consultants, suppliers, equipment manufacturers, and those in
academia. Courses will be taught by highly qualified, professional instructors, who are technical
experts as demonstrated by academic degrees, professional certifications and licenses, and
experience. CSM will use teaching pedagogies, materials, and practices conducive for adult
education and learning in a variety of environments, including in traditional classrooms, mine-
sites, and company facilities, as well as using online delivery to enhance course availability.
Within its training curriculum, CSM will address focus areas identified by the NORA Mining
Sector Committee. Primary NORA cross sectors of Hearing Loss Prevention, Respiratory
Health, Traumatic Injury Prevention, and Healthy Work Design and Well-Being are addressed
as topic elements in various training courses offered to the mining industry.

Public health relevance
Project Narrative The CSM Energy, Mining and Construction Industry Safety (EMCIS) program will provide a comprehensive approach intended to meet the safety and health training needs of the Western mining industry by providing a high quality, interactive training experience that targets mine workers and underserved audiences throughout the Western states, including safety and health professionals, mine management and supervision, contractors, consultants, suppliers, equipment manufacturers, and academia (faculty, staff and students). Through the training and educational activities offered by CSM, trainees will be exposed to critical concepts using best industry practices and adult learning techniques to facilitate the development and retention of fundamental skillsets essential to advancing safe and healthy work practices and the ability to identify and eliminate hazards. Future benefits of these efforts are to provide mine workers with the core values and knowledge necessary for positive, life-long improvements to the mining industry, as well as proactive practices and tools vital for reducing the risk associated with injuries and illnesses.